The Avidimer Platform - a molecular toolbox to accelerate proximity research and drug discovery

Project Summary / Abstract
The identify of small molecules or biologics that induce proximity of two targets is a promising and rapidly growing
modality in drug discovery. The premise has led to an explosion of new companies focused on proximity,
including targeted protein degradation mechanisms, stabilization of complexes, and modification regulation.
However, the commercial toolbox to enable success is largely lacking. One of the challenges is that most high-
throughput screening methodologies utilized for molecular glues, including DNA encoded libraries and affinity
selection mass spectrometry, do not inform on ternary complex formation, requiring costly and time consuming
validation assays. Traditional proximity assays such as HTRF and AlphaLISA rely on the availability of suitable
affinity reagents or require the incorporation of tags that can impact binding and protein behavior. They also
require high protein concentrations, leading to a burden on protein expression and assay artifacts that impact
data quality. The current challenge is to develop a molecular toolbox to enable the discovery of glues and other
proximity inducers, including the discovery of novel affinity reagents and optimized high-throughput screening
platform. Notably, the most common strategies for developing affinity reagents such as animal immunization are
prone to batch-to-batch variability and motivation to move away from animals. This proposal describes the
development of a novel application of phage display called the Avidimer Platform that reveals bispecific (two-
site) binders to one or more protein targets. The Avidimer Platform solves two challenges: 1) the development
of affinity reagents using a recombinant system to deliver a sustainable affinity reagent platform, eliminating
batch-to-batch variability and data can be shared as a DNA sequence by email or a purified protein, and 2) the
resulting Avidimer is a tool to enable HTS of molecular glues. This proposal aims to demonstrate the use of the
Avidimer Platform to develop an Avidimer for a well-characterized model system and develop an assay for
discovering glues. The proposal includes a benchmark against traditional glue screening methodologies.
Importantly, the Avidimer Platform is flexible, and can be used for virtually any proximity inducing target and
program and will have a significant overall impact on the proximity industry.

Public health relevance
Project Narrative This proposal addresses the lack of tools for the discovery of molecular glues and other chemically induced proximity modalities. The project aims to advance the development of our novel Avidimer Platform that facilitates the discovery of bispecific affinity reagents in tandem to identity bi-epitope binding intra- and intermolecularly. We will highlight the value and flexibility of this disruptive methodology by demonstrating proof-of-concept with a well characterized model system to enable proper benchmarking. The resulting Avidimer will then be used to screen a pilot set of small molecules to demonstrate a molecular glue HTS assay. Our proposal aims to highlight that the Avidimer Platform, which we intend to offer on a fee-for-service basis, will generate a molecular toolbox for virtually any proximity program to enable screening for small molecule proximity inducers or act as an inducer of proximity itself, addressing a critical unmet need in the industry and saving companies and researchers millions of dollars and expediting research programs.